Using Systems Immunology to Get at the Nature of Mood Disorders in HIV

Project Abstract
The proposal in this application will utilize systems biology approaches to get at the underlying pathogenesis of
mood disorders including major depressive disorder (MDD), bipolar disorder (BD), MDD combined with
generalized anxiety disorder (GAD) in people with HIV (PWH) virologically-suppressed on antiretroviral therapy
(ART). The overreaching goals are 1) to identify both common and mood disorder-specific gene expression
signatures in PWH on ART that correlate with the presence and severity of symptoms according to
computerized adaptive testing for mental health using comparative whole blood transcriptomic analysis while
carefully considering concurrent GAD, and/or prior childhood trauma; 2) to validate and mechanistically dissect
transcriptomic and metabolomic signatures of MDD, BD, and MDD with GAD in PWH on ART utilizing targeted
flow cytometry and metabolomics to validate differentially enriched genes and pathways; and 3) importantly, to
find therapeutics that could potentially reverse dysregulated pathways by applying a novel algorithm, drug
perturbation gene set enrichment analysis, to identify phenotypically-relevant, FDA-approved and
repurposeable therapeutics as potential novel treatment options for PWH with mood disorders. To complete
the experiments and answer these complex questions, an expert team has been assembled with the plan to
recruit a cohort of PWH virologically suppressed on ART in five groups: 1) MDD, 2) BD, 3) MDD and GAD, 4)
GAD, and 5) no mental health diagnoses. This cohort will be followed for 24 weeks and data will be collected
for transcriptomic, metabolomic and flow cytometric responses to the presence and severity of mood disorder
symptoms.

Public health relevance
Project Narrative Mood disorders are more common in people with HIV (PWH) than the general population and greatly affect the health and well-being of those afflicted. Importantly, mood disorders in PWH are associated with higher risk behavior and poorer adherence to HIV treatment. A better understanding of what causes symptomatic mood disorders in PWH holds the promise for improving our ability to make correct diagnoses, optimize treatment and identify ways for tracking treatment progress and success. We plan to enroll PWH on HIV medication who have symptomatic major depressive disorder (MDD) alone, bipolar disorder alone, MDD with generalized anxiety disorder (GAD), GAD alone, and PWH without psychiatric disorders to study both common and mood disorder-specific gene expression and metabolite signatures of underlying dysregulated immune system pathways.